Effect of blood donor sex and testosterone on predisposition to hemolysis in stored red blood cells

Project Summary
Blood donors are a genetically diverse population with numerous biological variables including sex, race, and
age that may affect red blood cell (RBC) storage and transfusion outcomes. We have demonstrated a sex
dichotomy in RBC predisposition to hemolysis, for which male RBCs from humans or mice exhibit enhanced
susceptibility to cold storage, osmotic shock, and oxidative stress. A key discovery of our studies is that
orchiectomy or testosterone replacement therapy (TRT) in mice significantly modulates RBC predisposition to
hemolysis in storage and after transfusion. This finding has alerted us to the potential risks associated with
TRT in blood donors. Testosterone therapies have been recently identified as of one of the most overused
medical practices in the US, and the lack of clear guidelines and risk assessment of RBC transfusion from TRT
patients deem such donors eligible for donation, except for cases of suspected polycythemia. Our preliminary
genome-wide association studies in 25 mouse strains suggested that sex differences in predisposition to
hemolysis involve gene networks surrounding p38 MAPK, which may intensify hemolytic response during
stress, and can be activated by testosterone. These observations inform our overarching hypothesis that
testosterone modulates erythroid cell differentiation and biology leading to sex differences in RBC
characteristics and kinase activity under hemolytic stress including cold storage. In the current proposal, we
use innovative human and mouse studies to evaluate the impact of donor sex and testosterone on transfusion
outcomes and to map out down-stream p38 MAPK signaling pathways that modulate RBC structure, function
and integrity during storage and transfusion. In Aim 1, we will define the impact of TRT in blood donors on RBC
storage and post transfusion recovery using a human to mouse transfusion model. In Aim 2, we will determine
the molecular interactions between testosterone and p38 MAPK, and identify the p38 MAPK signaling hubs
that impact RBC function and survival in storage. The impact of testosterone on p38 MAPK biology (Aim 2A)
will be defined at different levels of erythroid cell differentiation using human erythroid cell lines; in mature
RBCs from TRT patients before and 120 days after testosterone treatments; and in RBCs from mice
expressing attenuated p38 MAPK activity (B6.Cg-Mapk14tm1.1Dvb/J). In all experiments, we will monitor for
changes in protein expression downstream of p38 MAPK including MK2, HSP 27 and anion exchangr-1. Next,
we will use mouse and donor (NHLBI RBC-Omics) genome-wide association (GWA) databases of sex
differences in hemolysis to enhance discovery of signaling hubs associated with p38 MAPK and regulated by
sex. Outcomes from this project are likely to advance the field of transfusion medicine by assessing the risks
associated with transfusion of blood from TRT donors; providing new insights into the mechanisms that
mediate sex differences in RBC storage stability; and identifying signaling hubs that can be targeted
therapeutically to reduce the risk of hemolysis in transfusion practices.

Public health relevance
Narrative This proposal examines the impact of testosterone replacement therapy (TRT) in blood donors on red blood cell storage and post transfusion outcomes. The overarching goals are to identify the risks associated with TRT, and to map out sex-specific signaling pathways that modulate red blood cell structure, function and integrity during storage and transfusion.